Mechanism of Lassa virus-associated sensorineural hearing loss

PROJECT SUMMARY/ABSTRACT
Lassa virus (LASV), the causative agent of Lassa fever (LF), infects thousands of individuals annually in West
Africa and has a case fatality rate of up to 69% in outbreak scenarios. Survivors of LASV infection are at high
risk of developing bilateral, permanent sensorineural hearing loss (SNHL). Though the prevalence of SNHL
following LASV infection is 10-300 times greater than other common viral causes of hearing loss, the mechanism
driving this debilitating sequela is largely unknown. Prior research published by our laboratory implementing a
signal transducer and activator of transcription 1 knock-out (STAT1-/-) mouse model of LASV-associated SNHL
indicates that viral infection alone is not capable of inducing hearing loss. Alternatively, our results show that
immune injury mediated by CD4+ T cells is pivotal to SNHL development. However, how these CD4+ T cells
induce hearing degeneration remains to be determined. Currently, it is unknown whether the immune response
is auto-immune in nature, resulting from cross-recognition of inner ear proteins with viral antigens (i.e. molecular
mimicry), or a response to persistently infected inner ear cells. Additionally, it is unknown if the role CD4+ T cells
play in the antibody response to infection is responsible for SNHL development. The contribution of immune-
mediated injury to the development of SNHL has critical implications for vaccine design. If the damage leading
to SNHL results from the humoral response to viral antigen or auto-immune recognition of inner ear proteins
driven by their similarity to viral antigens, then vaccines implementing these antigens may induce hearing loss
in vaccine recipients. As a result, the objective of this application is to identify the role of antibodies and the role
and antigenic specificity of CD4+ T cells involved in SNHL development, allowing for assessment of the risks
associated with vaccination against LASV. To accomplish this, CD4+ T cells derived from mice vaccinated with
recombinant vesicular stomatitis virus (rVSV) expressing the LASV glycoprotein (GPC) or nucleoprotein (NP)
will be adoptively transferred into infected or uninfected STAT1-/- mice. Additionally, LASV immune sera will be
passively transferred into infected or uninfected STAT1-/- mice. These studies will allow for evaluation of our
central hypothesis, that immune-mediated damage driven by CD4+ T cells recognizing autoantigen in the
cochlear nerve is responsible for the development of SNHL following LASV infection. Using our STAT1-/- murine
model of LASV-associated SNHL, we propose to evaluate this hypothesis by pursuing two specific aims.
Specific Aim 1 will investigate the ability of antigen primed CD4+ T cells to induce SNHL. Specific Aim 2 will
investigate the ability of polyclonal anti-LASV antibodies to induce SNHL. These studies will comprehensively
evaluate the role of the T cell-mediated and humoral immune responses in the immunopathology related to
SNHL. Findings from the proposed research will be critical to achieving our long-term goal of developing safe
vaccines against LASV and identifying therapeutic targets to prevent SNHL.

Public health relevance
PROJECT NARRATIVE Lassa virus (LASV) infects thousands of individuals annually, one-third of which develop permanent, bilateral sensorineural hearing loss (SNHL). Prior research in our lab has demonstrated that CD4+ T cells play a critical role in hearing loss development, though the antigenic specificity of these cells and the mechanism by which they induce inner ear damage remains unknown. The goal of the proposed research is to elucidate the role of CD4+ T cells and antibodies in LASV-induced SNHL, the findings from which will have critical implications for LASV vaccine design.